Validation of Chlamydia virulence determinants by complementation

Project Summary/Abstract
More than 1.6 million cases of Chlamydia trachomatis infections are reported to the
CDC each year, making it the most commonly reported infectious disease in the country.
This bacterial pathogen infects human and other eukaryotic cells and only reproduces in
a host cell. Chlamydia research has been revolutionized by the recent development of
genetic methods to knockout or knockdown specific genes. However, a roadblock in this
genetic approach is the limited availability and utility of complementation methods to
express an exogenous copy of the gene. Current conditional expression in Chlamydia
relies on the Tet promoter, and it is not possible to independently control expression levels
for gene knockdown and also for a complementing allele. A further limitation is that
expression of the complementing allele from the chlamydial plasmid introduces gene
dosage effects.
This project will develop new complementation tools that will enhance the rigor of
genetic approaches used to study chlamydial gene function. In Aim 1, we will develop new
conditional expression methods for C. trachomatis. These studies will test induction
systems, including cumate and IPTG, and arabinose, that have been used in other
bacteria. In Aim 2, we will identify sites in the C. trachomatis genome where a gene can
be inserted without affecting other genes or the intracellular infection.
These studies have high potential impact because they will enhance the use of
complementation to confirm that a knockout or knockdown phenotype is due to a targeted
gene. The ability to independently control the expression of more than one exogenous
gene will also be broadly useful for studies of chlamydial gene function and host-
Chlamydia interactions. In addition, the identification of neutral sites for gene insertion will
be useful for creating C. trachomatis backbone strains that express additional factors,
such as Cre-Lox recombination systems or antibiotic resistance markers.

Public health relevance
Project Narrative Chlamydia is a major cause of sexually transmitted infections in the U.S., and more cases of chlamydial genital infections are reported to the CDC than any other infectious disease. Chlamydia research has been revolutionized by the recent development of genetic methods to knockout or knockdown specific genes. However, a roadblock in this genetic approach is the limited availability and utility of complementation methods to express an exogenous copy of the gene. This project will develop new complementation tools, which will enhance the study of chlamydial gene function.